Microbes and Human Malignancies

Persons with HIV and the acquired immunodeficiency syndrome (AIDS) have markedly elevated risks for developing Kaposi sarcoma (KS), non-Hodgkin lymphoma (NHL), Hodgkin lymphoma (HL), Merkel cell carcinoma (MCC), and anogenital cancers associated with human papillomavirus (HPV) infection. Importantly, people with HIV/AIDS have consistently been noted to have significantly reduced risks for breast and prostate cancers, compared to people in the general population. The primary cause of KS is infection with the KS-associated herpesvirus (KSHV, also known as human herpesvirus 8). Because KS among people with HIV/AIDS is closely tied to perturbations of immunity, which can be severe, the current study focuses on classical KS (cKS), which occurs predominantly in elderly adults in the Mediterranean area, people who have no overt immunologic abnormalities. This study primarily uses a population-based case-control study conducted in Sicily to identify cofactors for both KSHV infection and for cKS among those with KSHV. MCC is a rare but highly aggressive malignancy of neuro-endocrine cells that reside in the dermis. As MCC risk is increased with HIV/AIDS, pilot studies have been launched primarily to understand how MCC relates to the newly discovered Merkel cell polyomavirus (MCPyV). HL occurs approximately 15-fold more frequently in people with HIV/AIDS than in the general population. Collaborations with INSERM in Paris, France, are exploring the possiblity that HL is a manifestation of the immune reconsitution inflammatory syndrome (IRIS) that sometime occurs with initiation of effect antiretroviral therapy (ART). HL risk also has been associated with higher socioeconomic status and, specifically, with a hygienic childhood environment. To test this "hygiene hypothesis" a collaborative study is examining whether survivors of young adult HL have less diveristy in their fecal microbiome compared to co-twin controls who have not developed HL. To explore the reduced risk of breast cancer for women with HIV/AIDS descriptive analyses using data from the HIV AIDS Cancer Match and analytic analysis using data and specimens from the Women's HIV Interagency Study and the HIV Epidemiology Research Study. In addition, as postmenopausal breast cancer is closely tied to elevated levels of systemic estrogens, studies have been proposed to test whether systemic postmenopausal estrogens are related to differences in fecal microbes and particularly to microbial geta-glucuronidase activity that deconjugates conjugated estrogens, enabling them to reabsorbed from the gut. Collaborative studies, relying on a repository of biospecimens collected over a period of 20 years, have continued, with the goal to understand various malignancies and other conditions occurring in people with hemophilia and in people infected with the prototype human retrovirus, HTLV-I.